Novel Antimicrobial Approach to Treat Chemoradiation Resistant Cervical Cancer by Selectively Inhibiting Lactobacillus iners

Novel Antimicrobial Approach to Treat Chemoradiation Resistant Cervical Cancer by Selectively
Inhibiting Lactobacillus iners
We recently discovered a novel narrow-spectrum inhibitor of Lactobacillus iners, a commensal
pathobiont of the vaginal microbiome that is implicated in decreased survival in patients
undergoing treatment for cervical cancer. Current interventions cisplatin and radiation, become
less effective when the tumor-specific pathotype of L. iners is present. The inhibitor, a class IIb
two-peptide bacteriocin (GasK7B), kills L. iners at low nM concentrations but not beneficial
Lactobacillus species, potentially providing a new, much needed treatment strategy for women
with cervical cancer and dysplasia.
What is the proposed project: Previous work identified and characterized bacteriocins
purified from Lactobacillus paragasseri K7 cell-free supernatant. The proposed project is to
synthesize the most potent bacteriocin, GasK7B, and to characterize its in vitro potency,
selectivity, safety, and stability in an in vitro model. Finally, we will test in an in vitro model
whether synthetic GasK7B reverses the resistance of cancer cells to chemoradiation treatment
induced by cancer-associated L. iners induced resistance of cancer cells to chemo-radiation
treatment. Our goal is to establish synthetic GasK7B as a drug candidate, thus paving the way
for future for future IND-enabling studies.
Why is the important? This inhibitor represents the first known narrow-spectrum antimicrobial
agent that selectively kills L. iners without affecting most other beneficial lactobacilli of the
female reproductive tract, including L. crispatus. A selective inhibitor is important because an
oncogenic strain of L. iners has been strongly linked to cervical cancer and other species of
vaginal lactobacilli such as L. crispatus are associated with reproductive health and decreased
cervical cancer risk. Selective inhibition of the pathogenic L. iners could therefore open up new
prevention and treatment strategies for cervical cancer. The L. iners inhibitor would nicely
synergize with Osel’s live biotherapeutic product, LACTIN-V, that contains L. crispatus CTV-
05, that could help prevent recurrence of L. iners facilitated cervical dysplasia and cancer.
LACTIN-V has completed a Phase 2b clinical trial showing a significant reduction in recurrent
bacterial vaginosis (NCT02766023) and a replacement of L. iners with L. crispatus.
GasK7would facilitate the removal of L. iners. We refer to this approach as microbiome
deletion and replacement.
How will the project be accomplished? Preliminary data established that the L. iners
inhibitor is a selective bacteriocin, produced by an L. paragasseri strain K7. The inhibitor has
been purified from culture supernatants and characterized. We have synthesized the inhibitor
(small scale) and propose a larger scale synthesis to demonstrate that it inhibits cervical
cancer-associated L. iners strains, while still not inhibiting beneficial lactobacilli such as L.
crispatus. We will evaluate toxicity on vaginal epithelial cells, and organoid cultures in vitro.
Finally, we will test whether synthetic GasK7B reverses the L. iners-induced resistance of
cancer cells to chemo-radiation treatment using an in vitro model. These studies will enable
future pre-clinical work and move this inhibitor towards an IND for clinical testing.

Public health relevance
Project Narrative Two recent discoveries come together in this SBIR proposal: 1. Osel Inc. discovered a novel narrow spectrum inhibitor of Lactobacillus iners and 2. The Colbert Lab at MD Anderson Cancer Center identified a tumor-specific pathotype of L. iners (oncogenic L. iners) that is strongly associated with recurrence of cervical cancer and decreased survival following chemoradiation therapy. The proposed collaborative project between our groups will characterize the in vitro potency, selectivity, and safety of this inhibitor to establish it as a potential drug candidate for a first in class oncology product. This L. iners inhibitor administered alone or in combination with a live biotherapeutic product (LACTIN-V, that contains L. crispatus CTV-05: ClinicalTrials.gov NCT02766023) could open up a new treatment and prevention strategy, microbiome deletion and replacement, for women at high risk of HPV-associated cervical dysplasia and cancer.